Simulating the impact of a menthol ban in the US; translating the Canadian model

PROJECT SUMMARY
Menthol cigarettes comprise a substantial portion of the American cigarette market with prevalence estimates
reaching about 35% (FTC, 2016). Menthol is a flavouring agent added to cigarettes that masks the taste of
tobacco, induces sensory effects, and recruits and retains smokers. After a thorough literature review, a U.S.
Food and Drug Administration (FDA) advisory committee noted that banning menthol cigarettes would benefit
public health and announced intentions to regulate the sale of menthol in tobacco in November 2019.
However, in order to regulate menthol cigarettes, the FDA requires evidence on the expected impact of
regulating menthol and real world knowledge on the process of implementation. This study will use two
NIH/TRS funded longitudinal studies, the PATH in the US, and a cohort of smokers from Ontario, Canada to
develop a simulation model predicting how the Canadian ban, one of the only evaluated national level
implemented menthol ban in the world, would be reflected in the US given differences in age, sex, race,
menthol use, and expectations of change of behaviour. The goal of this project is to estimates of the impact of
the Canadian menthol ban to predict the impact of menthol regulations in the US on smoking cessation, health
outcomes, and health costs.

Public health relevance
PROJECT NARRATIVE The FDA has announced its intention to regulate the sale of menthol in tobacco, but little is known about how the real-world impacts of a menthol ban might translate to the US. This study will analyze two NIH/FDA funded studies to provide estimates of the effects of a menthol ban in tobacco implemented in Ontario, Canada and the baseline rates of tobacco use and cessation in the US by age, sex, race, and expectation, in order to develop a simulation model to translate the impacts of menthol regulations to the US, adjusting for demographics and differences in smoking behaviour. The findings of the present study will help to better understand the expected impacts of menthol regulations in the US and provide practical guidance on the development of regulatory policy.